Randomized Placebo Controlled Pilot Trial to determine the efficacy of an IL22 agonist (F-652) in patients with Alcoholic Hepatitis

PROJECT SUMMARY/ABSTRACT
Alcoholic hepatitis (AH) is a leading cause of liver-related morbidity and mortality with a remarkable paucity of
effective therapeutics. F-652, an IL-22 agonist, is a promising agent to treat patients with AH because of its
antioxidant, anti-apoptotic, anti-steatotic, anti-microbial, and pro-proliferative effects that have been
demonstrated in various experimental systems. A pilot study from our group in patients with AH has confirmed
safety and suggested efficacy of F-652, with no worrisome pharmacodynamic or pharmacokinetic patterns.
Based on the encouraging results from the pilot study, this application represents the next step to confirm
efficacy of the IL-22 agonist in patients with AH. The aims of this proposal are: 1. Determine the efficacy and
confirm the safety of an IL-22 agonist (F-652) in a randomized, placebo-controlled study in patients
with AH and MELD score 11-20 as demonstrated by improved MELD scores at 90 days. Patients with AH
and MELD score 11-20 (thus not candidates for the trial described in our linked application to RFA-AA-18-002)
will undergo a 1:1 randomization into an IL-22 agonist arm or a placebo (control) arm. Three doses of the IL-22
agonist or placebo will be administered at approximately 5-day intervals. The primary endpoint is improvement
(reduction) in MELD score by >25% at 90 days. Secondary endpoints include 30- and 90-day survival; Lille
score; and safety as determined by absence of serious adverse events (SAE) at 90 days. 2. Determine the
efficacy and confirm the safety of an IL-22 agonist (F-652) in a randomized, placebo-controlled study in
patients with AH and MELD score 21-28 as demonstrated by improved MELD scores at 90 days.
Patients with AH with contraindication to steroids (thus not candidates for the trial described in our linked
application to RFA-AA 18-002) and MELD score 21-28 will undergo a 2:1 randomization into an IL-22 agonist
arm or a placebo (control) arm. Three doses of the IL-22 agonist or placebo will be administered at
approximately 5-day intervals. Secondary endpoints include 30- and 90-day survival; Lille score; and safety as
determined by absence of SAE up to 90 days. We believe a pilot randomized controlled trial is a logical
extension of our preliminary studies which demonstrated safety and possible efficacy of the IL-22 agonist in
patients with AH. The investigators are uniquely positioned to perform the proposed study given substantial
breadth and depth of expertise related to AH, clinical trial conduct, and therapeutic development.

Public health relevance
PROJECT NARRATIVE This study will investigate the use of a new drug, IL-22 agonist, for treatment of alcoholic hepatitis. The success of this proposed research will result in a new treatment for patients with alcoholic hepatitis.